Genetic architecture of tissue factor expression

Project Summary/Abstract
Tissue factor (TF) is the primary initiator of blood coagulation. The expression of TF from the F3 locus must be
intricately regulated in a cell type-specific manner to ensure hemostasis following injury but prevent pathologic
thrombosis. Indeed, aberrant intravascular TF expression contributes to myocardial infarction, venous
thromboembolism (VTE), and stroke, while studies across species demonstrate that reduced TF dosage may
predispose to bleeding or protect against thrombosis. Nevertheless, the genetic architecture regulating F3
expression across diverse human tissues and disease states is largely undefined. Our central hypothesis is
that rare human genetic variation in the F3 promoter (Aim 1), coding region (Aim 2), and 3’ untranslated region
(UTR, Aim 3) disrupts the tight regulation of TF expression and its procoagulant activity to influence human
bleeding and thrombotic risk. Our preliminary studies integrate genetic and biochemical approaches to identify
new activators and the first repressors of F3 transcription, microRNAs negatively regulating F3 mRNA through
its 3’ UTR, and rare human genetic variation in the sequence elements that enable these interactions. We also
characterize the first human missense mutations in TF that impact its interaction with factor VII and/or factor X
activation. Because routine clinical assays of blood coagulation do not reliably capture the role of endogenous
TF, these individuals go undetected in human populations. In Aim 1, we will evaluate new transcriptional
activators and repressors of the F3 promoter. We will map the multiple but finite ways a cell can turn on F3
across human tissues, and define rare human genetic variation perturbing this stringent regulation. In Aim 2,
we will evaluate an expanded cohort of individuals with F3 null mutations and damaging missense mutations to
determine their impact on blood coagulation, factor VII activation, and human disease. In Aim 3, we will
characterize the role of microRNAs that negatively regulate F3 expression. Among these, we have identified a
microRNA whose action is suppressed by a SNP that is overrepresented in young patients with penetrant
thrombosis, suggesting a potential mechanism of thrombophilia attributable to unrestricted TF expression. By
systematically evaluating human genetic variation in the F3 promoter, coding region, and 3’ UTR, our findings
will establish the first F3 genotype-phenotype relationships in humans and provide a new lens through which to
interpret increasingly common human genetic testing that incorporates F3. The findings suggest new
mechanisms of human bleeding and thrombotic risk, as well as new therapeutic avenues to specifically target
pathologic TF expression.

Public health relevance
Project Narrative Tissue factor (TF) is the primary initiator of blood coagulation, so the production of TF must be carefully controlled to prevent thrombotic diseases including venous thromboembolism, heart attack, and stroke. This proposal seeks to comprehensively investigate mechanisms regulating how cells turn on or off the production of TF, and how these processes are disrupted by human genetic variation. These studies suggest that genetic variation in the gene for TF may impact blood clotting in humans and contribute to bleeding or thrombotic disease.